Translation Control of Pain Plasticity

In neurons, synaptic and intrinsic plasticity is dependent on the regulated control of mRNA translation.
Over the past decade our work has focused on how translation regulation signaling is involved in neuronal
plasticity that drives chronic pain. Our findings demonstrate that inflammatory and neuropathic injuries
stimulate translation regulation signaling pathways in dorsal root ganglion (DRG) nociceptors, neurons that
detect injurious or potentially injurious stimuli. The result of activation of these pathways is increased
excitability of nociceptors, behavioral signs of ongoing pain and sensitization to mechanical and thermal
stimulation. This body of work, supports the idea that therapeutics targeting translation regulation signaling
pathways can be used for the efficacious treatment of chronic pain. Our overarching hypothesis for this
continuing project is that MNK1 activation in nociceptors is the key regulatory factor for the translation of a
subset of mRNAs that encode proteins that augment the excitability of nociceptors causing enhanced pain
phenotypes. We will test this hypothesis using new transgenic mouse lines, cell type-specific translating
ribosome affinity purification (TRAP), highly specific inhibitors of MNK1/2 and new generation inhibitors that are
specific for MNK1. Our preliminary data indicates that the key MNK isoform for nociceptive behavioral plasticity
is MNK1. Based on our electrophysiology experiments we hypothesize that the site of action for this kinase is
in DRG neurons. Our first specific aim will test the hypothesis that MNK1 expression in nociceptors is a key
driver of behavioral expression of chronic pain. We have created a TRAP line that expresses L10a-tagged
ribosomes in neurons that express the Scn10a gene (Scn10aTRAP). In our second specific aim we will examine
how translation of specific mRNAs is regulated in preclinical neuropathic pain models with and without genetic
or pharmacological manipulations of MNK-eIF4E signaling. This will yield unprecedented molecular insight into
plasticity-driven changes in gene expression in nociceptors in neuropathic pain. The third specific aim will
focus on pharmacologically or genetically targeting mechanisms discovered using approaches in aims 1 and 2.
For instance, our TRAP approach captures translational upregulation of the Mrgrpd receptor in a neuropathic
model. We will use knockout mice to investigate the role of this receptor in sensory neuron excitability in
neuropathic pain. The proposed specific aims will highlight a key regulatory pathway for neuropathic pain and
give new insight into novel therapeutic targets for neuropathic pain.

Public health relevance
Our work is aimed at gaining a better understanding of molecular events that drive neuropathic pain and then using this knowledge to identify new molecular targets for neuropathic pain treatment. Our work has found a key signaling pathway that regulates nociceptor excitability changes that occur in neuropathic pain. An exciting aspect of this discovery is that this signaling pathway can be targeted by drugs that are in phase II clinical trials. The combined use of pharmacology, genetics and next generation sequencing technologies in our project will give new insight into mechanisms of neuropathic pain and will identify novel therapeutic opportunities to treat this highly prevalent and exceedingly difficult to manage neurological disorder